Pediatric Scientist Development Program

Project Summary
The Pediatric Scientist Development Program (PSDP) remains committed to building a diverse next generation
of pediatrician scientist leaders, including: (a) to recruit diverse pediatric fellows whose outstanding potential
for a successful investigative career can be developed in an intensively mentored setting and (b) to expand
and diversify the pipeline of superbly trained pediatric physician-scientists, who will catalyze cutting-edge
discoveries in child health and lead the pediatric departments of the future. Despite the successful history of
this program, the ongoing limited diversity of pediatrician scientist leaders and the changing landscape of
health care, academic medicine, and biomedical research requires ongoing modifications. The innovative
aspects of this resubmission include:
1. Sustain our diversity recruitment pipeline that includes a successful re-focus of the AMSPDC Frontiers in
Science (FIS) resident research experience as a diverse candidate pool and partnership with
organizations that train diverse academic pediatricians, to maintain a goal of ≥25% of applicants and
>50% scholars from underrepresented in medicine (URiM) backgrounds in this grant cycle
2. Harness the power of our robust, alumni network for near-peer mentoring and pipeline enhancement
3. Co-sponsorship of fellows by foundations focused on child health research for general pediatric and
disease-specific research training
4. Partnerships with complimentary training programs to aid PSDP fellow interdisciplinary training and
networking
5. Added flexibility for the clinical training component to focus on the disease area of research, building the
desired synergy in research and clinical training
6. New funding strategy that will support applicant pool flexibility and the fellow-to-faculty transition
7. Iteratively informed hybrid curriculum with “flipped classroom” interactive components, and a focus on
diversity and health equity aspects of pediatric research
8. Virtual platforms to enhance recruitment, selection, and professional development delivery
We project to train 55 PSDP Scholars in subspecialty fellowships (2023-2028). Of the 55 Scholars, 32 Scholars
will be funded by the NIH (includes one slot for HIV-related work co-funded by the Office of AIDS Research).
We will also have one intramural slot funded by the NICHD Division of Intramural Research. The PSDP will
build on lessons of more than 39 years to strengthen our national network, evolve career development
emphases and novel educational approaches, diversify the pediatric research workforce pipeline, and nurture
the next generation of diverse pediatric physician-scientists who will generate innovations children's health.

Public health relevance
Project Narrative Advancement in child health is threatened by the decline and limited diversity of pediatrician-scientists in the biomedical workforce. The Pediatric Scientist Development Program (PSDP) has implemented a comprehensive strategy to expand the boundaries of child health research and develop the research careers of rigorously trained, diverse pediatric physician-scientists. The PSDP's primary goal is to produce the next generation of diverse investigative pediatricians who will discover the causes and cures of childhood illnesses, recognizing that a diverse group of pediatrician physician-scientists is better equipped to address health issues affecting all communities and achieve maximum health impact.